Circadian Rhythms in Neuronal Models of Bipolar Disorder

Bipolar disorder (BD) is a psychiatric disorder associated with heritable polygenic risk factors. While clinically
heterogeneous, key clinical features of BD include disruptions in daily sleep and activity cycles indicating that
circadian rhythm disruption is an important part of the disorder in many patients. Circadian rhythms are
determined by molecular clocks comprised of “clock genes” whose expression is regulated by environmental
factors such as light and temperature. In recent years, our group and others have made progress in developing
cellular models of BD using induced pluripotent stem-cell (iPSC) derived neuronal progenitor cells (NPCs) and
neurons. We have determined that chronotype (time of day preference, “morningness”) in BD patients and
circadian rhythms in cells both predict the clinical response to lithium maintenance therapy. Using iPSC-based
methods to grow human NPCs and neurons, we found that neurons from BD patients have a hyperexcitable
phenotype that can be reversed by lithium selectively in neurons from lithium-responsive (Li-R) BD donors, but
not in cells from lithium non-responders (Li-NR). Presently, we propose to build upon this work and further
develop the iPSC-neuron model to further investigate circadian disruption in BD. In Aim 1, we will estimate the
contributions of polygenic risk factors to circadian rhythm phenotypes in BD in excitatory neurons. We will study
rhythms in iPSC-derived NPC and glutamatergic neurons grown from a well-characterized, extended family who
share high genetic risk for BD, but are discordant for the BD diagnosis. Presumably, cells from these genetically
similar individuals will contain BD risk genes across a gradient that can be quantified using polygenic risk scores
(PRS). By evaluating the relationship between PRS and rhythm parameters, we will estimate the aggregate
contributions of genetic risk for BD to the expression of circadian rhythm abnormalities. In Aim 2 we propose to
assess the contribution of BD-associated gene sets to circadian rhythms in neurons. Genome-wide association
studies (GWAS) of sleep and circadian phenotypes suggest the existence of a shared genetic basis for mood
disorders and chronotype. In this aim, we will study synchronized cells over a 24 h period to identify rhythmically
expressed genes in neural progenitor cells (NPCs) from BD patients and controls and describe rhythm
differences between diagnostic groups. We expect to find that many genes change their rhythm or lose rhythms
altogether in BD neurons. We will then use a molecular biology method called siRNA knockdown to reduce the
expression of candidate genes linked to BD and the circadian clock, and assess their loss of function in circadian
rhythm assays, under constant or temperature-entrained conditions. In Aim 3 we propose to measure circadian
rhythms in iPSC-derived GABAergic medium-spiny neuron-like cells. Our previous cell-based studies of BD
employed, excitatory glutamatergic neurons. Animal models of BD show important contributions of the clock
genes on dopamine projections to inhibitory, GABAergic medium spiny neurons (MSN) in the striatum. In this
aim, we will differentiate iPSCs from BD patients (Li-R and Li-NR) into inhibitory, GABAergic MSN-like neurons
using an established, high efficiency protocol. We will use the Per2-luc circadian rhythm reporter to measure
rhythms in live human GABAergic neurons for the first time and assess the effects of mood stabilizing drugs
such as lithium and antipsychotic drugs upon them. At the conclusion of the study, we will have a more advanced
understanding of which neurons lose rhythms in BD, which BD-risk genes are involved in the circadian disruption,
and how circadian disruption affects the function of neurons. This information may help to better identify lithium-
responsive BD patients and link them efficiently to effective treatments.

Public health relevance
Bipolar disorder (BD) is a common mental illness that affects 1-2% of the world’s population and ~100,000 veterans, causing mood symptoms, social/occupational disability and elevated rates of suicide. BD is associated with disruptions in daily (circadian) rhythms in sleep and activity. Lithium is an inexpensive, effective treatment for BD that protects neurons, and restores circadian rhythms. However, 30-50% of patients with BD fail respond adequately to lithium treatment. Lithium non-responsive patients often experience delays in receiving effective treatment and may require more expensive drugs. Our previous work indicates that circadian rhythm differences may help to identify lithium-responsive BD patients. Using newly-developed cell biology methods, we can now grow neurons from skin cells given by human donors. In this study, we use this approach to investigate circadian rhythm abnormalities in neurons from BD patients, and link circadian rhythm abnormalities with genetic factors previously tied to lithium-responsive BD.